Backup DNA repair in homologous recombination deficient cancers

Abstract
The maintenance of genome integrity in homologous recombination deficient (HRD) cancers is linked to the
backup repair of DNA double-strand breaks (DSB). Because endogenous DSB in tumors are associated with
DNA replication and rapid cell proliferation, there is prompt resection of any DSB to produce a 3’-single-strand
tail, which prevents non-homologous end-joining from binding to the ends. The principal backup repair pathways
are microhomology mediated end-joining or single stranded annealing in this setting. RAD52 has been identified
by our laboratory to be critical for the survival of cells with a defective BRCA1-BRCA2 pathway (HRD). When
homologous recombination (HR) becomes inactivated in human cancers, these alternative repair pathways are
used, producing the pattern of genome wide changes seen in these cancers. In this setting, RAD52 is a key
protein for DSB repair, which works either by the annealing of single-strand tails of broken DNA or by RAD51-
mediated strand exchange and gene conversion. The proposed work will determine the role of RAD52, HELQ
and POLQ in backup DSB repair. Additional proteins engaged in these functions will be discovered. Their
relative contribution to the different types of DSB repair and to the survival of HR-defective cells will be evaluated.
The consequences of this work will help to define new approaches to defining targets in the treatment of HRD
cancers and allow the development of new functional assays for backup DSB repair, with the ultimate goal of
defining the next generation of DNA repair inhibitors beyond PARP-inhibitors.
PHS 398/2590 (Rev. 06/09) Page 1 Continuation Format Page

Public health relevance
Narrative The repair of DNA double-strand breaks in cancer cells is frequently impaired. Inactivation of the breast cancer susceptibility genes, BRCA1 and BRCA2, place a vital dependence on backup DNA repair for survival. This project will investigate how the alternative backup repair pathways operate in cells, with the relevance being the opportunities for targeting the component proteins for optimizing cancer therapy in homologous recombination defective cancers.